Development of robust cloud-based software for co-simulation of biophysical circuit and whole-brain network models

3URMHFW 6XPPDU\
([SHULPHQWV DLPHG DW GLVFRYHULQJ KRZ WKH EUDLQ ZRUNV JHQHUDWH YDVW DPRXQWV RI GDWD WKDW VSDQ PXOWLSOH VFDOHV IURP
LQWHUDFWLRQV EHWZHHQ LQGLYLGXDO PROHFXOHV WR ZDYHV RI HOHFWULFDO DFWLYLW\ DFURVV WKH HQWLUH EUDLQ &RPSXWDWLRQDO
PRGHOLQJ SURYLGHV D ZD\ WR LQWHJUDWH DQG PDNH VHQVH RI WKHVH GDWD 7KURXJK WKH SDUHQW JUDQW 8(% ZH DUH
GHYHORSLQJ DQG GLVVHPLQDWLQJ 1HW3\1( D WRRO IRU GDWDGULYHQ PXOWLVFDOH PRGHOLQJ RI EUDLQ FLUFXLWV 7KLV WRRO SURYLGHV
ERWK D SURJUDPPDWLF DQG JUDSKLFDO KLJKOHYHO LQWHUIDFH WR WKH ZLGHO\XVHG 1(8521 VLPXODWRU WKDW IDFLOLWDWHV WKH
GHYHORSPHQW SDUDOOHO VLPXODWLRQ RSWLPL]DWLRQ DQG DQDO\VLV RI ELRSK\VLFDOO\ GHWDLOHG QHXURQDO FLUFXLWV 1HW3\1( LV
XQLTXH FRPSDUHG WR RWKHU QHXUDO FLUFXLW PRGHOLQJ WRROV HJ 1(67 %ULDQ LQ LQFRUSRUDWLQJ 1(8521 V PROHFXODU
UHDFWLRQGLIIXVLRQ 5[' PRGXOH ZKLFK DOORZV IRU GHWDLOHG VLPXODWLRQ RI LQWUDFHOOXODU DQG H[WUDFHOOXODU FKHPLFDO
VLJQDOLQJ OLQNHG WR HOHFWURSK\VLRORJ\ 6LJQLILFDQW SURJUHVV KDV EHHQ PDGH WRZDUGV DFKLHYLQJ WKH SDUHQW JUDQW JRDO RI
WUDQVIRUPLQJ 1HW3\1( LQWR D VROLG DQG ZHOOWHVWHG WRRO ZLWK D IXOO\IHDWXUHG *8, DQG ZLGHO\ GLVVHPLQDWLQJ WKH WRRO
DPRQJ WKH VFLHQWLILF FRPPXQLW\ 7KLV LV HYLGHQFHG WKURXJK D JURZLQJ XVHU EDVH WKH WRRO KDV EHHQ XVHG WR GHYHORS
DW OHDVW PRGHOV IURP RYHU LQVWLWXWLRQV ZRUOGZLGH DQG KDV FRQWULEXWHG WR RYHU SHHUUHYLHZHG SXEOLFDWLRQV
1HW3\1( KDV DOVR EHHQ LQWHJUDWHG RU LQWHUIDFHG ZLWK PXOWLSOH VWDQGDUGV WRROV DQG SODWIRUPV LQ WKH FRPPXQLW\
LQFOXGLQJ WKH 1HXUR0/ DQG 621$7$ WKH 2SHQ 6RXUFH %UDLQ (%5$,16 DQG 7KH 1HXURVFLHQFH *DWHZD\ 16*
+11 6FL8QLW6FL'DVK /)3\ DQG FRUH1(8521 WRROV
7KH JRDO RI WKLV VXSSOHPHQW LV WR HQKDQFH 1HW3\1( V LQWHURSHUDELOLW\ E\ WUDQVIRUPLQJ D SURRIRIFRQFHSW LQWHUIDFH
EHWZHHQ 1HW3\1( DQG 7KH 9LUWXDO %UDLQ 79% LQWR D UREXVW XVHUIULHQGO\ VFDODEOH DQG HIILFLHQW VRIWZDUH WKDW LV
SRUWDEOH DFURVV WKUHH FORXG HQYLURQPHQWV (%5$,16 7KH 1HXURVFLHQFH *DWHZD\ DQG *RRJOH &ORXG YLD 1,+
675,'(6 79% LV WKH ZRUOGZLGH UHIHUHQFH WRRO IRU VLPXODWLQJ PDFURVFDOH ZKROHEUDLQ QHWZRUN PRGHOV GHULYHG IURP
PXOWLPRGDO 05, DQDWRPLFDO IXQFWLRQDO DQG GLIIXVLRQ DQG ((* GDWDVHWV 7KH 79%1HW3\1( LQWHUIDFH WKHUHIRUH
DFKLHYHV D QHZ PLOHVWRQH IRU PXOWLVFDOH PRGHOLQJ OLQNLQJ PROHFXODU FKHPLFDO VLJQDOLQJ WR ZKROHEUDLQ QHWZRUN
G\QDPLFV 7KURXJK WKLV VXSSOHPHQW ZH ZLOO DOVR LQFUHDVH XVHU DGRSWLRQ DQG FRPPXQLW\ HQJDJHPHQW RI ERWK 1HW3\1(
DQG WKH 79%1HW3\1( LQWHUIDFH WKURXJK GRFXPHQWDWLRQ WXWRULDOV DQG H[DPSOH ZRUNIORZV GLVVHPLQDWLRQ DQG
WUDLQLQJ YLD ZRUNVKRSV DQG FRXUVHV DQG IROORZLQJ VRIWZDUH HQJLQHHULQJ DQG VKDULQJ EHVW SUDFWLFHV 7KLV SURMHFW
EURDGHQV WKH SRWHQWLDO XVHU EDVH RI 1HW3\1( E\ DWWUDFWLQJ QHZ XVHUV IURP WKH 79% DQG FORXG SODWIRUP FRPPXQLWLHV
DQG PRUH JHQHUDOO\ FOLQLFLDQV DQG UHVHDUFKHUV ZRUNLQJ ZLWK 05, ((* DQG 0(* GDWD 79% KDV EHHQ GRZQORDGHG
RYHU WLPHV DQG KDV EHHQ XVHG WR FRQVWUXFW DQG VLPXODWH RYHU LQGLYLGXDO FRQQHFWRPHEDVHG EUDLQ
QHWZRUN PRGHOV DQG FRQWULEXWHG WR RYHU SHHUUHYLHZHG SXEOLFDWLRQV 7KH SURSRVHG DFWLYLWLHV ZLOO WKHUHIRUH HQDEOH
ZLGHVSUHDG XVH RI D QRYHO RSHQ VFLHQFH WRRO WR LQYHVWLJDWH WKH LQWHUDFWLRQV EHWZHHQ ZKROHEUDLQ IXQFWLRQDO DFWLYLW\ DQG
WKH XQGHUO\LQJ FLUFXLW FHOOXODU DQG PROHFXODU FRPSRQHQWV DQG KHOS XQGHUVWDQG DQG WUHDW FRPSOH[ EUDLQ GLVRUGHUV

Public health relevance
Narrative Understanding the brain requires studying how its components at different scales interact with each other: from molecules moving inside neurons and synapses to waves of electrical activity across the entire brain. We propose interfacing the NetPyNE software tool, which models the interactions across molecules, cells and circuits, with The Virtual Brain (TVB) tool, which can model the whole-brain neural activity based on macroscopic magnetic resonance imaging (MRI) data. This will enhance the ability of researchers to understand and develop novel treatments for complex neurological and psychiatric disorders involving mechanisms across the full spectrum of brain scales, such as schizophrenia and Alzheimer's disease.